Tracking the opioid epidemic with social media: an early warning system

Project Summary
The opioid epidemic has continued to take a high death toll within the US, even accelerating
during the pandemic. Stemming and stopping the pandemic will require a multi-prong effort
along many health, social, even cultural dimensions. One important goal is to improve our ability
to monitor the epidemic–both the speed of detection of opioid-use hotspots and precise geo-
localization. Social media data represents an intriguing opportunity as it provides direct-report
posts from the population–which may be useful for detecting and localizing opioid activity.
However there has not been a careful systematic assessment of the utility (and pitfalls) for
broad use of social media. In this proposal, we outline a plan to combine Reddit and Twitter to
assess the ability to track opioid-associated mortality. We will focus on extracting mentions of
fentanyl in social media, as it is responsible for the majority of deaths. We will also focus on
modifiers that may be predictive of deadly use, particularly the use of opioids alone or in groups,
the functional availability of naloxone, and the use of comorbid drugs. We will explore the limits
of utility of social media data by aggregating it at multiple geo-spatial scales: national, regional,
state and county (or county-sets that aggregate sparsely populated counties). We will also
explore the time scales at which we can see relevant signals: annual, semi-annual, quarterly
and monthly. Thus, we have two aims:
1. To assess the ability of social media together to provide signals of opioid use (through
mentions of fentanyl and related synthetic opioids) that are correlated with mortality or proxies of
mortality at multiple geo-spatial and temporal resolutions.
2. To assess the utility of social media to provide information about group vs. solo use,
functional availability of naloxone and polypharmacy to modify the strength or urgency of opioid-
use signals.
The goal of our work is to generate a comprehensive preliminary assessment of the utility of
social media, as it exists in the real world and at multiple scales, as a component of the opioid
use surveillance system. Direct reports from the population may provide a useful “early warning”
system that when combined with other sources, will provide policy makers and public health
officials with a powerful set of tools for monitoring this public health crisis.

Public health relevance
Project Narrative The US is in the midst of an epidemic of opioid use and associated deaths. This complex problem requires a multi-prong effort, but a key component is the ability to track in a timely manner exactly where opioid use is high and dangerous, so that public health agencies can plan responses. We propose to use the posts to social media (Twitter and Reddit) to track the use of the most dangerous opioid, fentanyl, and to track the types of use that are most risky.